Research Support Core: Analytical Core

PROJECT SUMMARY: Analytical Core
Polychlorinated biphenyls (PCBs) are important Superfund chemicals that are known human carcinogens also
associated with neurological and metabolic disruption. The Analytical Core (AC) provides analytical services to
the ISRP to facilitate high-quality research on PCBs, including data, standard operating procedures, and peer-
reviewed publications that are standardized, efficient, and comparable across all ISRP matrices and projects.
The AC provides instrumentation and facilities, expert staff, training, data sharing platforms, and support for
method development. The AC will continue to accomplish these activities through five Specific Aims: Aim 1.
Maintain analytical quality assurance (QA) standards and protocols. Accurate, precise, representative,
reproducible, and comparable sample analysis is absolutely essential for all five ISRP projects and is a key AC
objective. The exceptional rigor of the QA protocol for PCB analysis provides a critical foundation for
discoveries by the ISRP projects. Aim 2. Facilitate high-throughput analysis in complex biotic and abiotic
matrices. The AC supports ISRP projects by extracting and analyzing samples for all 209 PCBs and 72 OH-
PCBs as MeO-PCBs in complex matrices, including: air samples collected on quartz filters, XAD resin, and
polyurethane foam; sediment, water, and pore water samples; human serum; laboratory animal tissues; plant
tissues; soils; microbial cultures; and polymers, paints, and pigments. To support new research directions
within the ISRP, we will expand our capabilities to include analyses of food matrices and the ability to quantify
all 837 possible mono-hydroxylated PCBs. Aim 3. Provide prioritized training and access to AC facilities. The
AC, in collaboration with the Research Experience and Training Coordination Core, provides prioritized,
standardized training in AC facilities and methods to graduate student and postdoc trainees, faculty, and staff
from all ISRP projects. Trainees also receive assistance in method development and use of instrumentation.
Aim 4. Support method development for complex matrices. The AC, in collaboration with ISRP projects, will
continue to develop, maintain, and update methods for high-throughput PCB and OH-PCB extraction and
analysis in biotic and abiotic samples. Separate but comparable methods are maintained across matrices to
facilitate integrated data analysis. Aim 5. Maintain analytical infrastructure. The AC maintains critical
infrastructure, including high-use analytical instruments, a sample database, and archives such as standard
solutions, samples, and sample extracts. The AC, in collaboration with the Data Management and Analysis
Core, will provide oversight to make data findable, accessible, interoperable, and reusable (FAIR) by ISRP
investigators. Overall, the AC is a fully-integrated support core that assists ISRP projects to meet all four SRP
mandates requiring methods for identifying human health hazards of superfund chemicals, detection,
assessment of exposure risk, and remediation.

Public health relevance
PROJECT NARRATIVE: Analytical Core The Analytical Core (AC) provides analytical services to the Iowa Superfund Research Program to facilitate high-quality research on polychlorinated biphenyls (PCBs). The AC provides instrumentation and facilities, quality assurance standards and protocols, expert staff, training, data sharing platforms, and support for method development.